Molecular Genetics Resource Core

Molecular Genetics Resource Core Project Summary
The Molecular Genetics Resource Core (MGRC) will provide a variety of services for the University of
Washington Center for Excellence in Opioid Research. We will provide state-of-the-art viral vectors for neural
circuit dissection, generate numerous viral-based CRISPR/Cas9 targeting vectors for in vivo molecular circuit
analysis, and provide access to platforms for the viral delivery of novel sensors and actuators developed by
UW addiction researchers. The NIDA-P30 MGRC will also generate novel mouse lines for UW addiction
researchers and provide access to existing mouse lines for researcher-initiated investigations. A major
provision of the NIDA-P30 MGRC will be hands on training in molecular genetics techniques for graduate
students, postdoctoral fellows, and qualified undergraduates. We will also provide a Summer Workshop for the
education and training of UW addiction research trainees. Collectively the resources, education, and training
provided by the NIDA-P30 MGRC will facilitate the rapid dissemination of cutting-edge research on the
molecular and genetic basis of opioid addiction and prepare the next generation of scientists for careers in
substance use disorder research.